Integrating Breast Cancer and Cardiovascular Disease Risk to Explore Decision-Making for Chemoprevention Among Racially/Ethnically Diverse Women at High Risk for Breast Cancer

Women with high-risk breast lesions, such as atypical hyperplasia (AH) and lobular carcinoma in situ (LCIS),
have up to a 4- to 10-fold increased risk of invasive breast cancer (BC) compared to women with non-proliferative
breast disease. Chemoprevention with selective estrogen receptor modulators (SERMs) and aromatase
inhibitors (AIs) have been shown in randomized controlled trials (RCTs) to reduce BC incidence by up to 50-65%
among high-risk women, with a 70-80% relative risk reduction among women with AH or LCIS. However,
chemoprevention uptake remains low at <15%. Cardiovascular disease (CVD) is also common in women, and
HMG CoA reductase inhibitors, or “statins,” are used for primary prevention, with a relative risk reduction of
~25% for major vascular events. About half of eligible U.S. patients are currently on a statin for primary prevention
of CVD. This contrasts with less than 15% of eligible high-risk women taking chemoprevention. While numerous
studies have been conducted to elucidate the complexities in BC chemoprevention decision-making, no studies
have been conducted within the context of preventive therapy for CVD. In this project, we will investigate where
and why, on the patient's journey from understanding their risk to discussing risk-reducing medications with their
provider, there is a divergence resulting in lower uptake of BC chemoprevention relative to the use of statins for
CVD. Using iterative equity-focused human-centered design, we will uncover differences in the decision-making
process (SERMs/AIs vs. statins), compare why a woman may opt out of SERMS/AIs as a preventive measure
but opt-in for statins, and explore if women can benefit from calibrating the chemoprevention decision-making
process in the context of more familiar statin preventive therapy for CVD. We developed and rigorously evaluated
decision support tools, RealRisks for patients and BNAV for primary care providers (PCPs), in RCTs, to increase
chemoprevention and genetic testing among high-risk women. In this proposal, we will refine these decision-
support tools based on a deeper understanding of chemoprevention uptake in the context of preventive therapy
for CVD. Our hypothesis is that the equity-focused human-centered design process, which is designed to
enhance understanding of low adoption of chemoprevention by contrasting decision-making with that of
individuals at risk of CVD, can clarify barriers and improve chemoprevention uptake. Specific aims are to 1) apply
human-centered design to refine RealRisks and BNAV for BC and CVD; 2) conduct a cluster randomized trial
with randomization of 60 PCPs to standard educational materials alone or combined with patient and provider
decision support to improve chemoprevention uptake among 200 racially/ethnically high-risk women, age 40-74
years; and 3) conduct an equity-focused evaluation of intervention implementation. This proposal addresses a
significant public health problem given the burden of BC and CVD mortality, particularly among racial/ethnic
minorities. It has the potential to illuminate previously unaddressed barriers to chemoprevention decision-making
in the context of interventions used to treat or prevent other chronic conditions, such as statins for CVD.

Public health relevance
Narrative Although breast cancer (BC) and cardiovascular disease (CVD) represent two of the most common causes of mortality among women, certain medications for these diseases, such as chemoprevention and statins, can lower a woman’s risk. Yet, low uptake of chemoprevention continues to perplex BC researchers, particularly given high-risk women’s expressed desire for risk-reduction options and the considerable resources expended to develop effective chemopreventive agents. By integrating CVD risk assessments into our existing decision aid, there is a potential to illuminate the previously unaddressed barriers to chemoprevention decision-making in the context of competing comorbidities like CVD and to educate women about ways to mitigate their risk for BC and CVD.